Coupling gene regulation to flagellar morphogenesis

Abstract
The bacterial flagellum is essential for motility and virulence for Gram-negative pathogens.
Flagellum assembly is complex and coupled to the controlled expression of more than 70 genes
in the flagellar and chemotaxis regulon. It takes many cell generations to assemble a completed
flagellum. For 30 years my lab has investigated mechanisms that couple flagellar gene expression
to assembly and the associated type III secretion (T3S) system. T3S is the only secretion system
in Biology that undergoes a secretion-substrate transition from one class of secretion-substrates
to another. One focus of this grant application is to determine the mechanism of the secretion-
specificity switch in flagellar and the related virulence-specific injectisome T3S systems. The
research will also determine how specific proteins are selected from the thousands present in the
cytoplasm and targeted for T3 secretion. We will also characterize key gaps in the understanding
of how flagellar gene regulation is coupled to assembly and how the entire flagellar regulon
responds to global gene regulatory systems.

Public health relevance
Narrative Salmonella has three Type III (T3S) systems: i) one for secretion of flagellar protein subunits and two for injectisome and associated virulence-effector proteins. T3S is arguably the most important route through which Gram-negative animal pathogens cause disease in humans. The characterization of the Salmonella flagellum assembly, T3S substrate targeting and coupled gene regulatory mechanisms will further our understanding of host-pathogen interactions, protein- secretion specificity, and nanomachine self-assembly. These complex mechanisms provide a wealth of potential antibiotic targets to inhibit T3S-associated pathogenesis. !